Dual Contrast pH-Weighted MRI for Stroke Imaging

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to develop a non-invasive imaging technique with high pH sensitivity to predict the
tissue fate for stroke, the leading cause of long-term disability. In acute ischemic stroke, a key therapeutic target
is to rescue the penumbra (i.e., tissue at risk of infarction) by restoring blood flow, however, the approval of
recanalization therapies has been limited to a time window of several hours because the risk-to-benefit ratio of
these therapies increases as time elapses. Given the large variations in infarct progression across individuals,
the benefit of treatment may outweigh the risk for some patients who were excluded by the currently prescribed
time window. To identify these patients and guide personalized therapy, there is an urgent need to develop a
metabolic imaging tool to 1) map the penumbra and 2) evaluate the risk of reperfusion injury. Recently, amide
proton transfer-weighted MRI (APTw) has shown pH sensitivity and gained increasing interest in the assessment
of ischemic tissue status. However, APTw suffers from contamination by large confounding effects which
precludes precise delineation of the mildly acidotic penumbra. Many approaches have been proposed to
minimize these confounding effects, but these approaches usually sacrifice pH sensitivity or lengthen scan time,
hindering their application to acute stroke imaging. Another intrinsic limitation is that the APT contrast in ischemic
tissue decreases exponentially with pH and becomes very low in the severe acidosis domain, affecting the
accuracy of predicting reperfusion injury. In this project, we will develop a ratiometric dual contrast (Rdual) pH-
weighted MRI approach that utilizes pH-sensitive signals from the amide and the guanidinol groups of
biomolecules while minimizing contamination from non-pH related effects, thus, greatly enhancing pH sensitivity
in both the mild and severe acidosis regimes. Our first Specific Aim is to develop and validate Rdual for better
probing of the tissue acidosis expected in the ischemic penumbra and the core. In the second and third Specific
Aims, permanent and transient MCAO animals will be studied to validate our hypotheses that Rdual MRI can
delineate the at-risk tissue with higher accuracy than conventional diffusion and perfusion-based methods, while
improving the prediction of the severity of reperfusion injuries. Our long-term goal is to refine this metabolic
imaging tool to help the clinical decision-making of recanalization therapies
neuroprotective drugs in preclinical research.
and the development of

Public health relevance
PROJECT NARRATIVE In acute ischemic stroke, a key therapeutic goal is to rescue at-risk tissue by promptly restoring blood flow. Current recanalization treatments that accomplish this cannot be applied to a majority of patients because they are also associated with risks and are only approved for narrow time windows. To better identify patients who may benefit from treatment, accurate mapping of at-risk tissue and evaluation of the risk of reperfusion injury are both critical yet they remain challenging for conventional imaging techniques. In this project, we propose to develop an MRI technique with high pH sensitivity and specificity, that can identify at-risk tissue and evaluate the risk of reperfusion injury. This technique can be a useful tool to help therapeutic decision-making and the development of neuroprotective drugs in preclinical studies.